IMPLEMENTING MULTICOMPONENT INTERVENTIONS TO TREAT BLOOD DONORS WITH FAMILIAL HYPERCHOLESTEROLEMIA

PROJECT SUMMARY
Familial Hypercholesterolemia (FH) remains woefully underdiagnosed and undertreated in the US. Recent
work from the PI demonstrated the ability to identify blood donors with FH at a similar prevalence as would be
expected in the general population. The overall objective in this mixed methods study is to apply
implementation strategies to improve treatment of blood donors with FH. The central hypothesis is that the
blood donation system can be an effective portal to increase receipt of treatment for individuals with FH. The
central hypothesis will be tested by pursuing four specific aims: 1) identify barriers and facilitators to receipt of
(low-density lipoprotein cholesterol) LDL-C treatment in blood donors with FH to inform implementation
strategy development, 2) develop and produce an implementation strategy bundle to increase LDL-C treatment
in blood donors with FH, 3) conduct a Type 2 implementation-effectiveness trial for LDL-C lowering in a
community-based blood donation center, and 4) evaluate the implementation bundle using mixed methods.
This research will be guided by the Consolidated Framework for Implementation Science Research (CFIR),
and will use Implementation Mapping, a theory- and evidence-based process, to develop, implement, and
evaluate these treatment enhancing strategies. In the first aim, semi-structured interviews will be used to elicit
barriers and facilitators of statin treatment from key stakeholders including: a) blood donors with FH b) family
members of donors c) blood donation personnel d) community physicians. Stakeholder feedback will be
iteratively integrated to develop, produce, and refine an implementation strategies bundle in the second aim,
that will be tested in Aim 3. The third aim consists of a two-arm randomized trial among blood donors with FH
comparing a) usual notification of high cholesterol or b) the implementation strategies bundle from Aim 2 with
the primary outcome of difference in change in LDL-C levels from baseline to 6 months. The fourth aim will
assess the acceptability, appropriateness, and feasibility of the implementation strategy bundle and will inform
development of a dissemination package to implement an FH program in other blood donor centers. The
research proposed in this application is innovative, in our opinion, because it incorporates the blood donor
program, an entirely new approach to identifying and treating FH. This novel portal of enhancing FH treatment
involves younger individuals who are less likely to seek regular medical care and complements traditional
strategies focusing on patients with medical homes. Ultimately, if successful, this program, informed by
implementation science methods, can be rapidly scaled to blood donation centers nationally involving 6.4
million donors annually, having an immediate impact on gaps in FH care.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it develops and assess a novel strategy to improve treatment of individuals with Familial Hypercholesterolemia (FH), namely identifying and treating them through the blood donor program. Once this strategy is developed in this proposal, it can be rapidly disseminated to blood donor programs nationally, making an immediate impact on FH care. Thus, the proposed research is relevant to part of the NHLB’s mission to promote the prevention of heart disease.